GENE THERAPY VECTORS FOR NON PROLIFERATING CELLS

The goal of gene therapy is the correction of specific genetic defects through the delivery of exogenous nucleic acids to target cells. Each of the currently-available gene delivery systems has specific disadvantages that present barriers to widespread use. In this phase I application, we propose the creation of a gene delivery vehicle that combines the ability to stably deliver a cargo gene into the genome of the recipient cell with the safety afforded by the use of a replication-deficient virus that is non-pathogenic in humans. This delivery system will be based upon the ungulate lentivirus, equine infectious anemia virus (EIAV). PROPOSED COMMERCIAL APPLICATIONS: Gene therapy is currently under investigation as a therapeutic tool for a wide range of clinical conditions. In fact, a number of gene therapy trials are ongoing. A safe and effective means for delivery of exogenous sequences to non-proliferating cells would be immediately applicable in all of the contexts where gene therapy is currently being applied or is being contemplated.